Admin Core

ABSTRACT
The Administrative Core of the Boston Area Diabetes and Endocrinology Research Center
(BADERC) is responsible for the proper operation of the Center. It is overseen by the
Center Director Dr. Jose Florez, in collaboration with the Associate Directors, Drs. Barbara
Kahn and Alexander Soukas, and the Center Program Manager Pamela Ricevuto. Senior
fiscal oversight is provided by Nancy Kingori. The Administrative Core sets the policies of
the Center, coordinates and supervises the activities of the BADERC research Cores, and
awards Pilot & Feasibility (P&F) grants. BADERC policies and goals are set by an
Executive Committee composed of BADERC investigators from the various BADERC
institutions (Florez, chair; Kahn, Soukas, Alexander Banks, Caroline Apovian, Sudha
Biddinger, Valentina Perissi, Camille Powe). Access to institutional resources and facilities
is assured by consultation with a senior Inter-institutional Advisory Board, chaired by
Katrina Armstrong, Chair of Medicine, MGH and composed of senior faculty from the major
participating institutions (Mark Zeidel, BIDMC; Joseph Loscalzo, BWH; Naomi Hamburg
BMC; Bridget Wagner, Broad; Harry Orf, MGH ex officio). The Administrative Core
assures the proper fiscal management of the research Cores, continuous quality
assurance, and delivery of services most needed and appropriate to the science pursued
by BADERC investigators. This function is coordinated by a committee of BADERC core
directors (Banks, Dennis Brown, Bradford Lowell, Barbara Kahn, Evan Rosen and David
Nathan) chaired by Dr. Banks. A collaborative program between BADERC investigators
and the Broad Institute is overseen by Dr. Wagner and is managed through the
Administrative core. The P&F grant program is overseen by Center Associate Director Dr.
Soukas with administrative support from Lynette Desharnais. A new Enrichment Program
is also overseen by Dr. Soukas with support from Ms. Desharnais. Issues of diversity,
equity and inclusion are monitored by Dr. Powe. Advice concerning opportunities for
collaborations, new technologies and advances in science relevant to diabetes is provided
by an external Scientific Advisory Board composed of the regional senior diabetes
investigators Drs. Steven Shoelson, Michael Czech and Gerald Shulman. Up-to-date
information about the science of BADERC investigators and the P&F grant program is
available on the updated BADERC website www.baderc.org.